Molecular Dynamics of Glioma Formation and DNA Damage Response by Mutant IDH1

Project Summary/Abstract:
Gliomas are the most common primary brain tumors in adults, a subset of which have mutations in the metabolic
gene isocitrate dehydrogenase 1 (IDH1). Cancer-associated IDH1 mutants (the most common of which is
IDH1R132H) are neomorphs that produce the oncometabolite 2-hydroxyglutarate [(R)-2HG], which is thought to
contribute to glioma formation. Mutant IDH (mIDH) inhibitors that block (R)-2HG production have been recently
shown to improve outcomes in lower-grade IDH-mutant glioma patients and are poised to become standard-of-
care. However, response to mIDH inhibitors is heterogeneous, and our understanding of how these drugs may
work in glioma has been severely limited by a lack of faithful animal models of lower-grade IDH-mutant gliomas.
In an effort to better understand these unanswered questions regarding mIDH1 biology, I made a
genetically engineered mouse (GEM) model of mIDH1-driven grade 3 astrocytoma that circumvents key
limitations of existing models and provides the opportunity to address fundamental unanswered questions
regarding mIDH biology in lower-grade gliomas. I leveraged this GEM and other models to show that IDH-mutant
gliomas are sensitive to de novo pyrimidine synthesis inhibitors (e.g. dihydroorotate dehydrogenase (DHODH)
inhibitors) due to an increased susceptibility of IDH-mutant cells to DNA damage caused by these drugs.
However, whether this sensitivity to DNA damage extends to other standard-of-care therapies, and the
mechanisms underlying these effects, is not fully understood. My overall objective is to leverage the key
advantages of my grade 3 IDH-mutant GEM to address fundamental questions regarding mutant IDH in glioma:
I will determine the response of my GEM model to mIDH inhibitors and evaluate molecular signatures of mIDH
inhibitor treatment, determine whether mIDH inhibitors and/or DHODH inhibitors alter response to radiation, and
identify mechanisms underlying how IDH-mutant gliomas respond to DNA damaging treatments.
I am a radiation oncologist with a research background in glioma biology and a long-term goal of directing
my own independent laboratory as an academic physician scientist. I aim to focus my research on understanding
the mechanisms driving glioma growth, with the goal of harnessing this knowledge to develop novel therapeutic
strategies. I am conducting research in the laboratory of Dr. William G. Kaelin, Jr., MD at Dana-Farber Cancer
Institute (DFCI), which I will continue during my proposed K08 research. As an Instructor, 80% of my time is
spent on research in the Kaelin lab and 20% is on patient care treating patients with glioma tumors. I have
assembled an expert Scientific Advisory Committee to help guide my research and career development: (1) Dr.
Stephen Elledge, PhD (Harvard Medical School), (2) Dr. Alan D’Andrea, MD, (DFCI), (3) Dr. Bradley Bernstein,
MD/PhD (DFCI), and (4) Dr. Samuel McBrayer, PhD (UT Southwestern). My clinical mentors are Dr. Patrick Wen
and Dr. Daphne Haas-Kogan, both world leaders in neuro-oncology. My training in this environment will be
outstanding preparation to achieve my long-term career goals as an independent investigator.

Public health relevance
Project Narrative: Gliomas are the most common primary brain tumors in adults, a subset of which harbor mutations in the metabolic gene isocitrate dehydrogenase 1 (IDH1). My project uses a novel genetically engineered mouse model of mutant IDH1-driven astrocytoma and other models to address how mutant IDH1 inhibitors affect glioma tumor biology, with the goal of leveraging this knowledge to develop new therapies. Collectively, these studies will address clinically relevant questions with direct translational applicability to patients with IDH1-mutant gliomas.